Role of cDC2 subsets in host protection and CD4T cell responses in melanoma

Project Summary
Despite recent successes, many melanoma patients still fail to respond to immunotherapy and there is a
pressing need for identifying novel therapeutic targets. The primary goal of immunotherapy is to activate tumor-
specific immune responses, in which tumor-specific T cells play a crucial role. Although cytotoxic CD8T cells
have long been the main focus of research on tumor-specific immunity, growing evidence shows the
contribution of CD4T cells to tumor rejection, especially in tumors treated with immunogenic therapy. However,
the mechanism of CD4T cell activation in melanoma is less well understood compared to that of CD8T cells.
Type 2 conventional dendritic cells (cDC2s) have high antigen presenting capacity to activate antigen-specific
CD4T cells, but their role in tumor immunity has not been fully understood due partially to the phenotypic
heterogeneity within this cell type. We previously identified CD301b+ DCs as the major cDC2 population in the
mouse skin and showed that they transport antigens from the skin to the draining lymph node and efficiently
prime antigen-specific CD4T cells. This proposal focuses on understanding their role in host protection and
CD4T cell activation in experimental melanoma models in mice. To understand how cDC2 cells respond to the
tumor microenvironment at the molecular level, we employ a novel technique of single-cell RNA sequencing to
identify subset-specific gene expression changes in cDC2 subsets during melanoma progression. In parallel,
we use targeted cell depletion approaches to identify the cellular mechanisms of cDC2-depedent host
protection in both untreated melanoma as well as in those treated with immunogenic therapy. These
experiments will collectively provide comprehensive understanding on the role of cDC2 subsets in melanoma
and potentially reveal new cellular pathways that lead to activation of melanoma-specific CD4T cells.

Public health relevance
Project Narrative CD4T cells are generally considered as the master regulator of adaptive immunity, but how CD4T cells are regulated in melanoma is poorly understood. In this grant application, we propose to directly examine the role of cDC2 cells, a conventional dendritic cell subset with high CD4T cell priming capacity, in CD4T cell activation in mouse models of melanoma. Our goal is to understand the basic mechanism of CD4T cell activation in melanoma and identify the critical cDC2 subsets and their molecular signatures that can potentially be future therapeutic targets.